Increasing Veterans' Social Engagement and Connectedness (CONNECTED)

Background: Social isolation is a global public health threat and a negative social determinant of health
(SDoH) that affects 1 in 5 adults in the U.S. and contributes to $6.7 billion in annual healthcare spending.
Significance: Affecting roughly 43% of Veterans, social isolation is highly prevalent among Veterans,
particularly those with a history of mental illness. Social isolation contributes to cardiovascular diseases,
dementia, depression, suicidal ideation, and premature death. To date, social isolation remains largely
unaddressed as a negative SDoH in healthcare systems. Current efforts to address social isolation are limited
by lack of diverse participant samples, rigorous methodologies, and involvement of healthcare systems to
systematically assess and reduce social isolation.
Innovation and Impact: To address these gaps, the proposed project will test a novel and feasible program to
intervene on social isolation among diverse Veteran populations in the VHA healthcare system. We propose to
test the effects of the Increasing Veterans’ Social Engagement and Connectedness (CONNECTED)
intervention on social isolation among Veterans. CONNECTED uses an innovative approach by integrating two
existing evidence-based care models: peer services and patient navigation to address social isolation among
Veterans in VHA primary care clinics. CONNECTED involves three key services delivered by peer specialists
via telehealth over 8 weeks: 1) peer support, which includes person-centered assessment of factors driving
social isolation; 2) psychosocial interventions to address Veterans’ social isolation (e.g., goal setting,
supportive therapy, and group-based social engagement activities); and 3) navigation (i.e., connecting
Veterans to social resources in the community and the VHA) to help expand their social networks. Because
prior social isolation studies have not prioritized inclusion of younger and racially/ethnically diverse samples,
we will oversample these groups using stratified random sampling.
Specific Aims: We aim for a randomized controlled clinical trial comparing CONNECTED to an attention
control group. Aim1: Test the effects of CONNECTED on social isolation at 2-, 4-, and 8-months from baseline
compared to the control group; Aim2: Test the effects of CONNECTED on secondary, health-related
outcomes; and Aim 3: Conduct formative and pre-implementation evaluations to inform future implementation
processes.
Methodology: Aims 1 and 2 involve delivering the intervention to (N=264) Veterans in VHA primary care
clinics. Data from Aims 1 and 2 will be analyzed using general linear models. In Aim 3, we will describe
Veterans (n=20) and providers’ experiences (N=10) with the intervention using semi-structured interviews to
identify barriers and facilitators to CONNECTED’s future implementation. We will also survey peers and peer
supervisors (n=20) from VISN10 VA facilities (n=13) and interview a subgroup of survey completers (n=8) to
evaluate factors that may affect potential adoption of CONNECTED in VHA and to identify future
implementation strategies. Qualitative data from Aim 3 will be analyzed using an inductive/deductive approach.
Next Steps & Implementation: Should this trial be successful we will work with our operational partners to
implement CONNECTED in the VHA. Our next step will also involve the evaluation of CONNECTED’s core
elements and its implementation in diverse VHA facilities.

Public health relevance
Social isolation is a negative social determinant of health (SDoH) that affects 1-in-5 adults in the U.S. and 43% of Veterans. Social isolation is estimated to cost the nation $6.7 billion annually in federal healthcare spending. Yet, social isolation has rarely been the direct focus of healthcare interventions. The proposed project is a randomized controlled trial that seeks to test the effectiveness of the Increasing Veterans’ Social Engagement and Connectedness (CONNECTED) intervention on social isolation among diverse Veteran groups in primary care clinics. CONNECTED involves three key services delivered by peers via telehealth through individual and group sessions over 8 weeks: 1) peer support, which includes person-centered assessment for social isolation, 2) psychosocial interventions to address social isolation, and 3) navigation (i.e., connecting Veterans to social resources). Findings from this study will contribute to the VA’s efforts to address SDoH among Veterans and to provide high quality, person-centered, and equitable care to all Veterans.